Outreach Core

OUTREACH CORE – ABSTRACT
Cancer incidence and mortality rates for racial and ethnic minorities and other underserved and vulnerable
populations are substantially higher in Chicago than the national average for most cancers (Illinois State Cancer
Registry). Addressing these disparities demands culturally and linguistically relevant community-driven
approaches. In 2015, a consortium comprised of community members and three major academic institutions in
Chicago, University of Illinois at Chicago (UIC), Northeastern Illinois University (NEIU), and the Robert H. Lurie
Comprehensive Cancer Center of Northwestern University (NU-LCC), secured NCI U54 funding to establish the
Chicago Cancer Health Equity Collaborative (ChicagoCHEC), which aims to foster rigorous and meaningful
research, education, training, and community outreach/engagement to advance health equity. Through the
original U54 award, the Outreach Core identified community needs, and provided leadership and programmatic
support for community-based cancer education, engagement, and outreach activities. In this renewal, the
proposed activities of the ChicagoCHEC Outreach Core will build upon the existing strengths, prior and ongoing
work, accomplishments, and lessons learned from the first U54 award to elevate ChicagoCHEC’s collective
impact on reducing cancer inequities. A major area of the Outreach Core’s focus for the next five years will be
to develop targeted cancer support efforts for underserved and vulnerable populations. These include the
following non-mutually exclusive groups: people with disabilities, sexual and gender minorities, men of color, and
low-income cancer survivors. Proposed community engagement approaches span the cancer continuum,
encompassing prevention, screening and early detection, community-based education, and cancer treatment
and survivorship. Specific aims of the Outreach Core are to: (1) Foster community partnerships and conduct
ongoing needs assessment to identify new and innovative areas of opportunity, including outreach research, for
community-engaged activities that will reach individuals from health disparities populations; (2) Implement
outreach and education activities across the cancer continuum; (3) Foster opportunities for building cancer health
equity research capacity among community partners, faculty, and students; (4) Plan, implement, and evaluate
NCI National Outreach Network activities locally; and (5) Rigorously evaluate achievement and progress of the
Outreach Core’s stated aims using a comprehensive evaluation strategy. A highly effective and diverse tri-
institutional leadership team with complementary expertise will lead these activities, supported by experienced
Community Health Educators with strong clinical and community networks. A Community Steering Committee
will guide the development and implementation of the proposed outreach and engagement activities. The
Outreach Core will leverage each ChicagoCHEC partner academic institution’s numerous ties to Chicago’s
diverse neighborhoods and community organizations in its activities collectively aimed at advancing cancer
health equity.